Treatment of parathyroid neoplasia by pharmacologic cdk4/6 inhibition

Project Summary:
Parathyroid cancer is a rare, but typically incurable malignancy. Prolonged elevation of parathyroid hormone
and accompanying hypercalcemia cause significant morbidity and mortality. Surgery remains the primary
treatment and recurrence is seen in ~50% of patients. A precision medicine approach may improve outcomes
for patients whose disease is surgically incurable. Pharmacologic cdk4/6 inhibitors have recently been
introduced for the treatment of various cancer types, with mixed results. These drugs might be effective in the
30% of parathyroid cancers which harbor cyclin D1 amplification. The aim of this study is to assess the efficacy
of pharmacologic cdk4/6 inhibitors in a cyclin D1-driven mouse model of parathyroid neoplasia. Transgenic
mice will be treated with the cdk4/6 inhibitors palbociclib or abemaciclib, alone or in combination with
cinacalcet. These pre-clinical studies will help to determine if pharmacologic cdk4/6 inhibitors are likely to be
effective in parathyroid carcinoma patients whose tumors harbor amplifications/rearrangements of cyclin D1,
potentially establishing a new treatment for patients with surgically-incurable parathyroid cancer.

Public health relevance
Project Narrative: This research will examine the effectiveness of a new class of cancer drugs, known as cdk4/6 inhibitors, in a mouse model of parathyroid tumors. This research will help us determine if these drugs are likely to be effective in certain patients with parathyroid cancer.